PIWIL4 and piRNAs in RSV Infection

PROJECT SUMMARY/ABSTRACT
Acute respiratory tract infections are a leading cause of morbidity and mortality in children worldwide.
Respiratory syncytial virus (RSV) is a major cause of lower respiratory tract infections in children, elderly and
immunocompromised patients, as well as of asthma exacerbations. No effective treatment or vaccine for RSV
is currently available, and many fundamental questions regarding the pathogenesis of RSV-induced lung
disease have yet to be answered. Small non-coding RNAs (sncRNAs) have been found to regulate many
cellular processes, including host-virus interactions. RSV infection can significantly alter the expression profile
of host sncRNAs, and several types of sncRNAs, such as miRNA and tRFs, have been shown to play a
significant role in RSV replication and virus-induced host responses. In recent studies, we found that RSV
infection alters the expression of piwi RNAs, (piRNAs), one of the largest classes of sncRNA molecules
expressed in animal cells. Although the role of piRNAs was initially confined to gonad development, recent
studies have identified specific expression profile of piRNAs from multiple organs and cell types, and different
profiles have been associated with several diseases, including various types of cancers, cardiovascular
diseases, autoimmune and neurodegenerative disorders. Surprisingly, almost nothing is known regarding
piRNA generation/function and PIWI proteins in the context of viral infections. Identification of patterns and
details of human sncRNAs generation has significantly helped understanding how they modulate host
responses in the context of viral infections. The outcome of the proposed studies will lead to new knowledge
regarding the role of piRNAs in RSV-induced cellular responses, potentially identifying novel therapeutic
targets and/or bio-markers for disease diagnosis and prognosis.

Public health relevance
PROJECT NARRATIVE Respiratory syncytial virus (RSV) is associated with bronchiolitis, pneumonia and flu-like syndromes, as well as asthma exacerbations, and it is considered a serious public health problem, for which no effective treatment or vaccine is currently available, while many fundamental questions regarding the pathogenesis of its associated lung disease still need to be answered. This project seeks to investigate novel molecular mechanisms regulating host cell responses following infection with RSV. In the long term, our studies could lead to new pharmacologic strategies to prevent or treat serious lower respiratory tract infections, therefore reducing RSV- associated morbidity and mortality.